Core B – Medicinal and Process Chemistry

Project Summary – Core B
The Medicinal Chemistry Core (Core B) of the Antiviral Countermeasures Development Center (AC/DC) will be
composed of the combined capacity of the Emory Institute for Drug Development (EIDD) and the research group
of Professor Dennis Liotta. This Core will centralize all AC/DC chemistry operations including medicinal
chemistry, scale-up synthesis, process development and preformulation profiling into a highly efficient team that
will reduce redundant research around chemotypes that are of interest to multiple Projects. It will also interact
closely with all AC/DC Projects and Cores to allow for an unprecedented level of synergy and integration
throughout the Center. The AC/DC will have a compelling set of leads, early leads and validated hits in its pipeline
at various stages of development and optimization at the onset of operations. These compounds present a wide
array of chemotypes that will be pursued in parallel, including broadly active ribonucleoside leads, non-
nucleoside viral polymerase inhibitor leads, and viral protease inhibitor hits. New validated hits emerging from
Core F (HTS) will also be advanced through iterative SAR optimization to ensure an ongoing robust pipeline of
drug candidates at various stages of development. Finally, Core B will develop scale-up processes and
preformulation profiles to support the advancement of late leads throughout the AC/DC.